Project 2: Dietary Interventions in Asthma Treatment

Although mouse allergen and pollutant exposures have been linked to asthma morbidity in poor minority populations, these factors do not account for most of the observed morbidity, so that additional environmental factors almost certainly contribute to asthma morbidity in this population. One intriguing environmental factor is diet since the population that is most affected by asthma morbidity and mortality-poor, predominantly African American populations- have a

Public health relevance
Findings from the proposed studies will lend insight into impact of dietary factors on inner-city asthma. Specifically, the project will determine if dietary interventions can improve oxidative stress status, inflammation, and allergic asthma. The findings may support the use of dietary supplement or overhaul of diet in the treatment of allergic asthma.